Evolutionary adaptation and spatial organization of signaling in the Mitotic Exit Network

Project Summary
Sensing and processing information through signaling cascades is an essential part of cellular life. A few
signaling cascades such as the MAP kinase and Hippo pathways are ubiquitous among eukaryotes yet
perform different functions across organisms. Although these pathways are well-studied, how they evolve to
take on new functions and adapt to new inputs remains poorly understood. The Mitotic Exit Network (MEN), a
Ras-like GTPase signaling cascade and yeast homolog of the Hippo pathway, provides a unique opportunity to
study this question. In the MEN, the same core signaling components operate in distinct manners under
different developmental trajectories. During yeast mitosis which occurs through an asymmetric cell division
called budding, the MEN is scaffolded onto the spindle pole bodies (SPB, the yeast equivalent of centrosomes)
and responds to spindle position through its GTPase Tem1. During meiosis, where budding is suppressed and
thus no need to sense spindle position, MEN signaling is no longer organized at the SPBs, and it is unclear
whether Tem1 is still required for MEN activation and what signal it may respond to. To understand the
adaptation of the MEN under distinct cellular contexts, this proposal will test the hypothesis that this adaptation
is enabled partially by different activation mechanisms of the MEN kinase Cdc15, the effector kinase of Tem1,
between mitosis and meiosis. COVID-19 pandemic related research restriction and the passing of my mentor
Dr. Angelika Amon during the pandemic severely disrupted my research progress and delayed my career
development plans. While I made significant progress toward the aims laid out in my original K99 proposal and
am currently preparing a manuscript on the project, my transition to independence was delayed for a year
relative to the originally proposed timeline. A funded extension will allow me to develop critical skills in protein
biochemistry, in vitro reconstruction, and yeast meiosis to dissect the mechanisms of Cdc15 regulation in
mitosis versus meiosis. I will accomplish this with the guidance and training from my mentor Dr. Stephen Bell
(biochemistry, single molecule, and in vitro reconstruction) and Dr. Elçin Ünal (yeast meiosis, member of my
advisory committee). Furthermore, a funded extension will also allow me to complete my current search in
securing an academic position and enable my transition into an independence investigator. In summary, the
additional training and support I will receive during the extended K99 period will equip me with the knowledge
and skills necessary to study the mechanisms underlying signaling adaptation of the MEN in different cellular
contexts and create a strong foundation for an independent research career in understanding the evolutionary
adaptation of cellular signaling.

Public health relevance
Project Narrative How signaling pathways evolve to adapt to new inputs and why certain spatial organization of signaling components are conserved across species while others are rewired remain poorly understood. This proposal will address these questions using the yeast Mitotic Exit Network (MEN) as a model system taking advantage of the intriguing observation that the core components of the MEN are rewired from mitosis to meiosis to adapt to different developmental inputs while the nucleolar localization of the MEN effector, the protein phosphatase Cdc14, is evolutionarily conserved from yeast to human. Results from this work will advance our understanding of the evolution and spatial organization of cellular signaling, whose dysfunction underlies a number of diseases such as cancer.